Biostatistics

Project Summary/Abstract - BIOSTATISTICS SHARED RESOURCE
The UNMCCC Biostatistics Shared Resource supports basic, clinical, population/community, and translational
cancer research by providing cost-effective, full service biostatistical support for researchers with interests
spanning the full range of research activities in the UNMCCC. Faculty Director V. Shane Pankratz, Ph.D.
(CCPS) supervises the Resource, which is operated by statistical faculty and staff. Administrative support is
provided by the UNMCCC Research Administration. The Resource provides an array of statistical support to
researchers in the UNMCCC, including the provision of statistical expertise in study designs and data types
arising across the cancer research continuum, the provision of protocol reviews to the Protocol Review and
Monitoring Committee (PRMC) and others, assistance in the development of new research projects, support in
conducting and monitoring ongoing research projects through the Data Safety and Monitoring Committee
(DSMC), and other means, the provision of analytical support for research studies, and access to specialized
statistical software. Members of the Resource work closely with the Analytical & Translational Genomics and the
Bioinformatics Shared Resources to enhance the acquisition of knowledge from NGS and other genomic data.
Requests for the support of new projects are made through a simple on-line system, and Resource members
collaborate closely among themselves and with other researchers to monitor work flows and ensure timely
completion of research projects. The current goals of the Resource are to: 1) provide members of the UNMCCC
Research Programs with biostatistical support in the development and conduct of clinical trials and laboratoryand population-based research projects, and the analysis of data from these projects, 2) provide a statistical
resource to UNMCCC members that supports projects requiring only a short-term and limited level of
biostatistical input, 3) ensure study integrity, high data quality, and patient safety in all research conducted within
the UNMCCC through the scientific review of clinical research protocols, including formal participation in the
PRMC, and through the monitoring of clinical trials conducted within the UNMCCC via participation in the DSMC
and 4) enhance the research capacity of UNMCCC members by providing educational opportunities and by
disseminating information on available resources, technologies, and services. The Resource Director and other
Resource members work closely with UNMCCC research programs to identify biostatistical support needs and
to develop collaborations between statisticians and other researchers. During the past 5-yr project period, 70
UNMCCC members across all three UNMCCC Research Programs used the Resource to carry out 181 projects,
with 98 published or in-press manuscripts. In the reporting year of July 2018 – June 2019, UNMCCC members
were responsible for 100% of total Resource usage and were supported by 23 peer-reviewed grants.